Role of Bruch Membrane Heparan Sulfate in Drusenogenesis in Age-Related Macular Degeneration

ABSTRACT
Age-related macular degeneration (AMD) is the leading cause of blindness in developed countries. This
devastating disease affects 196 million individuals and is predicted to increase to 288 million by 2050. Most of
these patients suffer from the early and intermediate “dry” AMD and are currently without treatment options
due to an incomplete mechanistic understanding of this complex disease. In early and intermediate AMD,
large diffuse lipoprotein-rich deposits, named drusen, are deposited in the macula, and impair vision.
Although drusen are a hallmark feature of AMD, the mechanism of drusenogenesis is unresolved. Drusen
form between the retinal pigmented epithelium basal lamina (RPE BLam) and the inner collagenous layer
(ICL) of Bruch’s membrane (BrM). RPE BLam and BrM are composed of glycosaminoglycans (GAG),
including heparan sulfate (HS). Modification of GAG side chain residues creates binding sites for numerous
growth factors, enzymes, and lipoproteins. This structural variation makes GAGs one of the most complex
macromolecules found in nature and has been shown to be altered with aging and disease, including as an
initiating event in subendothelial deposition of lipoproteins in atherosclerosis. Our understanding of GAGs in
general, their role in BrM health, and how they change with aging and diseases, such as AMD, has lagged far
behind other macromolecules despite their central role in biology. Our preliminary data show that HS is
increased in AMD BrM compared to age-matched controls. In addition, AMD macula is rich in highly sulfated
HS disaccharides (N-, 2-O and 6-O sulfation). Notably, Apolipoprotein E (APOE), a critical component of both
lipoproteins and drusen, has binding sites to N-, 2-O and 6-O sulfated HS. In this proposal, we propose to
test the hypothesis that an age-related increase in HS sulfation (N-, 2-O and 6-O) induces lipoprotein
retention in BrM in early AMD. To address this hypothesis and elucidate the pharmacologic potential of this
pathway, we propose the following aims: Aim 1: Determine what AMD risk factors are associated with BrM
GAG composition. Aim 2: Determine if BrM HS structure or content promote lipoprotein binding in AMD. Aim
3: Determine if HS sulfation regulates lipoprotein retention in vivo in mice. If successful, the proposed
experiments will establish alterations in HS sulfation as an initiating event in drusenogenesis and identify
therapeutic targets for HS and lipoprotein binding for AMD. The mentored training program is designed to
acquire new skills to support a career as a physician-scientist with expertise in glycobiology and lipoprotein
biology. Towards this goal, a team of mentors have been assembled at UC San Diego, with expertise in
heparan sulfate and lipoprotein metabolism.

Public health relevance
PROJECT NARRATIVE Age-related macular degeneration is the leading cause of vision loss in the elderly in industrialized nations. The majority of patients suffer from the early and intermediate “dry” form of the disease and are without treatment options. In this training grant proposal, we have developed a mentored training plan in glycobiology to understand the extracellular matrix dysregulation responsible for initiating AMD and inform the development of novel therapeutics.